Develop Multiphoton Magnetic Resonance Imaging

Abstract
Magnetic resonance imaging (MRI) is an indispensable non-invasive imaging technology for diagnostic
medicine and basic research. Today’s MRI assumes single-photon excitation. More specifically, for each nuclear
spin, a single photon accompanies the transition between energy states which creates MRI signal. This photon
must resonate near the Larmor frequency. The goal of this project is to explore and develop an entire new class
of MRI that utilizes multiphoton excitation. That is, instead of the usual single-photon resonance, the proposed
technique can excite multiphoton resonances to generate signal for MRI by using multiple magnetic field
frequencies, none of which are near the Larmor frequency. Only the total energy absorbed by a spin must
correspond to the Larmor frequency. Multiphoton MRI is a radical new way to perform MRI. It introduces new
flexibilities for excitation, encoding, contrast generation and reception. The project will explore and develop the
essential hardware, pulse sequences, excitation and receiving techniques for clinically feasible multiphoton MRI.
If successful, multiphoton MRI will pave the road for many new avenues to generate novel MRI images and
benefit human health.

Public health relevance
Project Narrative The overarching objective of this project is to develop multiphoton MRI. Multiphoton MRI is a radical new way to generate MRI images that has the potential to transform MRI. The project is to create the necessary hardware, software and methodology for clinically feasible multiphoton MRI.